Biotype-specific evolution

PROJECT SUMMARY
Cholera is presently caused by O1 serogroup, El Tor biotype V. cholerae, which emerged in 1961 to initiate the
ongoing seventh pandemic. The prior 6 cholera pandemics were caused by O1 serogroup classical biotype V.
cholerae. Over the past 60 years, classical biotype has essentially disappeared from the aquatic environment
and as a cause of cholera. However, the reasons for this are unknown. V. cholerae in the environment is found
in association with numerous vertebrate fish species. The proposed work will use a zebrafish model for V.
cholerae that can investigate interactions between V. cholerae and natural aquatic hosts covering the entire
infectious cycle. Previous work found dramatic differences in the timeline of zebrafish colonization by classical
and El Tor biotypes, with classical being cleared within 72 h and El Tor able to colonize for up to 14 days with
high levels of bacterial replication. We hypothesize that this prolonged fish colonization and replication provided
a strong selective advantage to El Tor, allowing it to replace classical in environmental niches. V. cholerae El
Tor biotype has 2 pathogenicity islands termed VSP-1 and VSP-2 that classical lacks. Data from preliminary
experiments indicate an El Tor strain deleted for VSP-1 has a normal fish colonization phenotype, whereas a
strain deleted for VSP-2 is defective in prolonged colonization. Therefore, it is likely that gene(s) within VSP-2
are essential for prolonged colonization. Aim 1 of this proposal will use a progressive deletion strategy to identify
and characterize gene(s) within VSP-2 that are important for prolonged colonization and assess whether such
genes are sufficient to prolong classical colonization. On the host side, innate and adaptive immunity provide
protection from invading pathogens. Fish have innate immune responses very similar to mammals, as well as
adaptive immune responses that develop over the first 4-6 weeks of life. We hypothesize that classical biotype
is rapidly cleared by a strictly innate response, whereas El Tor can only be cleared by an adaptive immune
response. Aim 2-1 of this proposal will test these hypotheses using larval zebrafish, which have a fully functioning
innate response but an undeveloped adaptive response. Aim 2-2 will further test the hypothesis that El Tor
clearance requires adaptive immunity by using zebrafish mutants that are defective in adaptive immunity.
Completion of the proposed work, using zebrafish as an environmental V. cholerae host model, will significantly
advance our understanding of V. cholerae evolution and selective pressures in a natural reservoir. The long term
goal of this work is to better understand the V. cholerae life cycle, how it contributes to pathogenesis in humans,
and identify new strategies to combat V. cholerae disease and transmission.
.

Public health relevance
PROJECT NARRATIVE Vibrio cholerae is a major human pathogen in many developing countries, with an estimated 3-5,000,000 new cases and 100,000 deaths each year each year. The goal of this proposal is to characterize how V. cholerae has evolved to better survive in the aquatic environment, leading to cholera outbreaks. Achieving this new level of understanding will enable future research to identify new therapeutic targets and/or targets for environmental remediation.